QUANTIFICATION OF GLYCOSYLTRANSFERASE PROTEIN LEVELS IN HESC & DERIVED CELLS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The goal of this collaborative project is to determine relative changes in glycosyltransferase protein levels in hESCs and derivative cell lines using MRM-based mass spectrometry quantification.